The Impact of Macrophage Origin on the Pathogenesis and Treatment Resistance of Pancreatic Cancer

PROJECT SUMMARY
The prognosis for pancreatic cancer (PC) patients is poor. Data from several groups has shown that
significant infiltration of PC by macrophages decreases the efficacy of chemo-, radiation- and immunotherapy
in an animal models and correlates with poor clinical outcomes in patients. The classical assumption has been
that these tumor-associated macrophages are derived from circulating monocytes. Recent changes in the field
of developmental biology suggest this assumption is not entirely correct and offer a radically new view of
macrophage origins in many tissues. It is apparent that tissue-resident macrophages can also arise from
embryonic precursors that seed tissues in pre- or perinatal periods. In our recently published study we
established a key role for embryonically-derived macrophages (eMACs) in PC progression. We demonstrated
that: 1) eMACs expand exponentially during PC progression by in situ proliferation, 2) eMACs are more potent
drivers of PC progression than their monocyte-derived counterparts, and 3) eMACs have a distinct tissue
remodeling phenotype that significantly enhances PDAC fibrosis in vivo. Thus, a further study of the
interactions between various origin-based subsets of macrophages in PC may lead to an understanding of the
recalcitrant nature of the disease. Our overall hypothesis is that epigenetically poised, embryonically
derived pancreas-resident macrophages are critical regulators of pancreatic fibrosis and early disease
progression in PC. To test this hypothesis we will:
Aim 1. Determine the mechanisms by which eMACs drive fibrosis and early PDAC pathogenesis.
Aim 2. Determine the origin-specific epigenetic drivers of eMAC pro-fibrotic and pro-tumor activity.
Aim 3. Determine the impact of eMACs on therapeutic responsiveness.
Impact: Our classical assumption was that all TAMs are derived from monocytes, however this may not be
true. The fact that embryonic- and/or tissue resident-derived TAMs might impact PDAC progression and
response to therapy has significant implications for both basic science and clinical care.

Public health relevance
PROJECT NARRATIVE These studies seek to understand how macrophages derived from either monocyte or embryonic origins might differentially impact the progression and therapeutic responsiveness of pancreatic cancers. A better understanding of how origin specific macrophage subsets regulate pancreas cancer progression will help us refine ongoing therapeutic approaches targeting this disease.